Human Health Exposure Analysis Resource (HHEAR) Data Center

Project Summary
NIH funded the Human Health Exposure Analysis Resource (HHEAR) a coordinated network of laboratories
and statistical and data science resources, designed to provide access to comprehensive exposure analyses
using biological samples collected in studies of children’s health. The HHEAR Data Center (DC) is located at
the Icahn School of Medicine at Mount Sinai. The NIH created a seven-year initiative, the Environmental
Influences on Child Health Outcomes (ECHO) program with the aim of bringing separate children’s cohorts
together into one large ECHO-wide Cohort so that ECHO investigators and the wider scientific community can
study the effects of early environmental exposures on child health and development. To support ECHO’s
goals, the HHEAR lab network has been analyzing biological samples collected by the cohorts for a wide
variety of environmental exposure biomarkers. The laboratory results from these analyses are uploaded to the
HHEAR DC for quality assurance (QA) and quality control (QC) before the results are transferred to the ECHO
Data Analysis Center (DAC). The purpose of this supplement application is to enable the HHEAR DC to
support the activities of ECHO that are beyond the current work scope of HHEAR but within the abilities of the
DC. Through this supplement application, we will: generate core sample ID’s, provide review of the HHEAR
lab results including consultation with the labs on this review; perform quality control and assurance on the
lab results; produce a lab results QC report; and coordinate data flow support to integrate laboratory
analyses into the ECHO Data Analysis Center.
The proposed supplement activities are needed to increase the ability of the HHEAR DC to extend our
originally proposed work to accommodate the additional work that is required to provide collaboration, support
and services to the ECHO network. This supplement will ensure that the HHEAR Data Center can provide the
means for the efficient working of the ECHO program and provide continued support that will contribute to the
overall success of the ECHO program.

Public health relevance
Project Narrative Taking advantage of our already established HHEAR DC Quality Control/Assurance processes will result in increased production with greater efficiency; decreased data transfer time; and increased returns on NIH investment. It will allow the ECHO program to continue their intent to advance our understanding of how the environment influences children’s health and development and to accelerate children’s environmental health research.